Core 07: Clinical Research Resources Core

The Clinical Research Resources (CRR) Core met its goals in the second funding cycle by developing and growing a multi-institutional research infrastructure and is now poised to grow further by deepening the partnership with clinical trial units at three more institutions and by supporting multi-institutional grants across the LA CaTS network. There are four Specific Aims for this next cycle defined as follows: Specific Aim 1: Support clinical activity and ensure efficient and effective data collection in ongoing clinical trials including the All of Us study l. Specific Aim 2: Expand support through development of infrastructure and human resources for clinical and translational research at Louisiana State University Health Shreveport and the VA and UMC hospitals in New Orleans. Specific Aim 3: Enhance competitive clinical and translational research programs through training and professional development. Specifically, we will add a new marketing, recruitment and retention focus to our ongoing training activities. Specific Aim 4: Extend the reach of CRR beyond the traditional clinical trial unit to engage a wide range of populations within the state. Specifically, we will collaborate with the Community Engagement and Outreach (CEO) Core to establish and maintain a network of disease-focused community members in New Orleans, Baton Rouge, and Shreveport. Network members will be recruited through CEO as well as Federally Qualified Health Centers and Agriculture Extension agents working with local and rural populations. Accomplishment of these aims will significantly enhance the infrastructure for clinical research in the State of Louisiana, leading to improved health outcomes and reduced gaps in healthcare delivery for State residents with chronic diseases such as cancer, obesity, and diabetes.